Control of germline stem cells and the switch to meiotic development in C. elegans

Project Summary/Abstract
A key step in animal germ cell development is the switch in fate from stem/progenitor cells to entering meiotic
prophase en route to gametogenesis. Disruption of this switch results in infertility and/or aneuploidy. Conserved
features of the developmental transition include stem cell self-renewal followed by initiation of the meiotic
program (e.g., homologous chromosome pairing, synapsis, double strand break formation) and repression of
mitotic cell cycling. Multiple pathways function in control of the switch, resulting in genetic redundancy that has
impeded the identification of key regulators. Furthermore, the regulatory process is heavily reliant on
posttranscriptional control mechanisms. Studies of this switch in animals have progressed farthest in C. elegans.
This is in part because the developmental transitions follow a convenient spatial continuum, allowing facile
analysis of changes in cellular state (e.g. levels of regulators, changes in chromosome behavior) in wild type and
mutant backgrounds. We have identified three parallel redundant pathways that control the switch in C. elegans.
Yet, important questions remain.
How is the switch spatially controlled? Here we focus on one of the pathways, the SCFPROM-1 pathway,
an E3 ubiquitin ligase that functions in protein degradation. SCFPROM-1 induces meiotic entry and inhibits mitotic
cell cycling, and its activity is controlled by PROM-1 proteins levels that rise from a base in stem cells to a peak
at meiotic entry. Proposed studies of the spatial control will uncover how the activity and function of SCFPROM-1
is regulated and is coordinated with the other two known pathways, how meiotic entry is repressed in stem cells,
and how mitotic cell cycling is repressed at meiotic entry.
What are the missing regulators that execute the switch? The regulatory network contains significant
genetic redundancy and there is evidence for missing regulators. Leveraging a novel in vivo genetic system we
developed to synchronously switch stem cells to meiotic entry, we are employing genome-wide integrated
transcriptomics, translatomics and proteomics, followed by genetic functional analysis to identify missing
regulators. This combined genomics and genetically targeted functional analysis will overcome genetic
redundancy in the developmental switch, which is difficult in less tractable organisms.
Our overall goal is to complete the regulatory network and delineate processes governing an essential
step in germline development, which will inform studies in other animals. Our investigations will uncover new
developmental, cellular and molecular principles that are important for human health. This fundamental basic
research in a genetic model organism will produce foundational knowledge for understanding cell fate switches,
as well as the origin of birth defects and fertility.

Public health relevance
Project Narrative Defects in the key developmental process where germline stem cells switch to entry into meiotic prophase and gametogenesis can result in the formation of aneuploid progeny and infertility. Since ethical and practical issues limit studies in humans, research in model organisms is essential. This work will complete the regulatory network and delineate processes governing this essential step in germline development, informing on how the switch is executed in other animals, including humans.